Interaction Of Non-opioid Peptides With Opioid Receptors

The hipocampus is a brain area known to be involved in learning and memory in both humans and animals. In addition, the activation of opioid receptors in the hippocampus can disrupt memory formation, and synchronous neural processes. Several studies to date have provided evidence that non-opioid peptides, such as cholecystokinin (CCK), can disrupt opioid-mediated processes, including analgesia. Therefore, we have begun studies to evaluate the hypothesis that the actions of CCK on opioid-mediated effects is due to a form of heterologous desensitization of the mu opioid receptor following activation of CCK-B receptors. These studies are conducted in the rodent brain slice preparation using whole-cell electrophysiological techniques. Studies completed to date indicate that activation of mu opioid or CCK-B receptors on hippocampal GABAergic interneurons demonstrate opposite effects on membrane potential and cellular excitability, such that CCK-B receptors excite, and mu opioid inhibit interneuron activity. Studies completed in the last period were designed to examine whether cannabinoids, as well as opioids, will interact with CCK receptors. We have expanded this study to include cannabinoids because it has become increasingly clear that the cannabinoid type 1 receptor (CB1) is located almost exclusively on CCK-containing interneurons in the hippocampus. Therefore, our first study examined the actions of cannabinoid receptor agonists on these CCK containing interneurons. This work was published in the European Journal of Neuroscience. In the next year, we will examine more directly, interactions between CB1 receptors and CCK, as well as continue our studies of CCK/opioid interactions in the hippocampus.